Balancing Muscle Force in Patellofemoral Pain

For the first aim, the data processing was complete and a paper is now in review. The following are the primary findings:
More than 66% of adolescents with patellofemoral pain will continue to report pain after 2 years, and 1 in 3 still have pain after 5 years.
Approximately 70% of adolescents with patellofemoral pain will stop or reduce sports activities due to pain, which can impact their education and career paths, their social interactions, and their mental health.
Understanding the mechanisms that underpin the persistence of patellofemoral pain in adolescents is crucial for the development of effective intervention strategies to prevent a lifetime of recurring pain and potential joint degeneration.
This study identified no difference in the distribution of vastus medialis and lateralis muscle forces in adolescents with patellofemoral pain, compared to adolescents with no knee pain.
By considering the moment arm relative to the patellar centre, this study identified no difference in the distribution of vastus medialis and lateralis muscle torque between the two populations.

For the second aim, an automatic segmentation tool was successfully built, demonstrating an accuracy superior to previous similar techniques. A manuscript based on this work is now in review